Regulators of immune complex mediated neutrophil antigen presentation

ABSTRACT
Autoimmune disease is the third most common disease category after cancer and heart disease that afflicts
23.5 million Americans. This grant renewal continues to focus on the role of neutrophil FcγRs in autoimmune
diseases. However, it has shifted from understanding the role and regulation of neutrophil FcγRs in neutrophil
recruitment following intravascular IgG-immune complex deposition in glomerulonephritis (GN) to examining
how engaging FcγRs converts neutrophils into highly immunogenic antigen presenting cells (nAPC) and their
contribution to autoimmune disorders effecting the kidney. This new direction is based on our recent studies
showing that engaging mouse FcγRs or human FcγRIIA or IIIB on mature neutrophils with IgG-complexed
antigen (immune complexes) leads to their differentiation into highly active APCs. These cells are
comparable to cDCs in their ability to activate naïve T cells and cross-present soluble antigen to CD8 T cells,
properties previously assigned almost exclusively to cDCs. Engaging FcγR with an anti-FcγRIIIB-antigen
conjugate recapitulates the activity of immune complexes and its administration in FcγR humanized mice
generates nAPCs in vivo that elicit robust acquired immunity. Studies in lupus patient samples indicate that
nAPC frequency in blood correlates with clinical disease scores, which suggests that nAPCs are pathogenic.
Single cell transcriptional analyses and validation studies implicate the pioneer transcription factor PU.1 in
neutrophil to nAPC conversion and suggest that transcriptionally defined neutrophil populations convert to
two nAPC subsets with distinct gene signatures and functionality. Furthermore, we provide evidence that
FcγR internalization and a defined epigenetic regulator play a key role in conversion. Here we propose to 1)
Elucidate the functionality of nAPC subsets and the role of epigenetic regulation in neutrophil to nAPC
conversion, 2) Elucidate the route of intracellular trafficking of FcγR bound to antibody-antigen complexes
and identify mechanisms of FcγR induced generation of immunogenic nAPCs using CRISPR-Cas9 based
genetic screens, and 3) Interrogate the role of nAPCs in Antineutrophil cytoplasmic antibody (ANCA)-
associated glomerulonephritis and the effect of antigen-tolerized nAPCs in disease outcomes. Dysregulation
of the immune system is the basis of many autoimmune diseases for which current treatments are effective
in only a subset of patients and are often neither curative nor durable. Neutrophils with APC markers have
been observed in diseases from autoimmune diseases to cancer. Results from this proposal may provide
important insights into the molecular and cellular pathways governing neutrophil conversion to immunogenic
APCs. This could provide insights into the pathogenesis of many immune related disorders and lay the
groundwork for new treatments that potentially non-invasively generate a large pool of antigen carrying APCs
designed to elicit tolerance or acquired immunity.

Public health relevance
PROJECT NARRATIVE The third most common disease category in the U.S. after cancer and heart disease is autoimmune disease. Yet, treatments mainly rely on immunosuppressive drugs with significant side effects that are not curative and do not induce long term remissions. Our studies propose to reprogram neutrophils, abundant in blood and traditionally viewed as short-lived cells evolved to kill pathogens, into cells that re-educate autoreactive T cells to be tolerant to self-antigens, which in turn could reverse autoimmunity.